Mammalian Developmental Genetics And Animal Models Of Hu

The Section on Mammalian Molecular Genetics studies the molecular genetics of patterning, axis formation and organogenesis in the developing mouse embryo. Current work examines key control elements of this process. A scenario of protein-protein interactions emerges that control every aspect of the body plan. We have utilized a loss-of-function approach to identify basic components of protein complexes that activate target genes during the course of development. Over the years, or laboratory has carried out extensive studies on LIM-homeodomain proteins. These Lhx gene products are important transcriptional regulators of invertebrate and vertebrate embryonic development. They are involved in early patterning events, in the development of the nervous system, and in organogenesis. Their action is facilitated by cofactors that were identified by their ability to dimerize and to bind to the LIM domain, a specialized zinc-finger structure present in Lhx gene products and in a number of other nuclear proteins. In vertebrates, these LIM-binding co-factors are known as Ldb, Nli or Clim, in Drosophila as Chip, and in C. elegans as Ldb1. Protein-protein interactions involving Ldb/Nli/Clim (henceforth referred to as Ldb) and Chip are not restricted to LIM domain-containing factors but can involve a host of other transcriptional regulators as well. There is ample evidence to support the notion that the Ldb and Chip cofactors are essential components of developmental programs controlled by transcriptional regulators. More recently, the Rlim cofactor was identified and shown to negatively control transcription factors by targeting Ldb proteins for degradation. Furthermore, competition of transcription factors for binding to Chip or Ldb can also alter developmental cell fates. The mammalian Ldb1 protein is found in multi-protein complexes containing various combinations of LIM-homeodomain, LIM-only, bHLH, GATA and Otx transcription factors. These proteins exert key functions during embryogenesis. We have established that targeted deletion of the Ldb1 gene in mice results in a pleiotropic phenotype, revealing fundamental roles of Ldb1 in key developmental decisions. Firstly, there is no heart anlage in the Ldb1 null mutant embryo. Our data suggest that Ldb1 gene function is essential for proper allocation of cardiac mesoderm to the heart field in the gastrulating embryo. Abnormal migration of the heart mesoderm in the mutants may abolish inductive interactions of this tissue with anterior endoderm and thus prevent heart development. Also, head development is severely curtailed in the mutant, and head structures are truncated anterior to the hindbrain. In about 40% of the mutants, posterior axis duplication is observed. The expression of several Wnt inhibitors is curtailed in the mutant, suggesting that Wnt pathways may be involved in axial patterning events regulated by Ldb1. Abnormal organizer gene expression during gastrulation may account for the observed axis defects in the Ldb1 mutant embryos. Finally, we observed in the Ldb1 null mutant conceptus severe defects in mesoderm-derived extraembryonic structures, including the allantois, blood islands of the yolk sack, primordial germ cells, and the amnion, attesting to a key role of Ldb1 in mesoderm formation. In an effort to identify additional components of Ldb/Chip-containing nuclear protein complexes, we generated HeLa cells that express FLAG and HA epitope-tagged mouse Ldb1, purified nuclear complexes with the aid of the tags, and identified constituent proteins by mass spectrometry of tryptic peptides. We identified Ssdp proteins (previously described as sequence-specific, single-stranded-DNA-binding proteins) as components of Ldb1-associated nuclear complexes in these cells. Ssdp proteins are associated with Ldb1 in a variety of additional mammalian cell types. This association is specific, does not depend on the presence of nucleic acids, and is functionally significant. Genes encoding Ssdp proteins are well conserved in evolution from Drosophila to humans. Whereas the vertebrate Ssdp gene family has several closely-related members, the Drosophila Ssdp gene is unique. In Xenopus, Ssdp encoded by Drosophila Ssdp or mouse Ssdp1 mRNA enhances axis induction by Ldb1 in conjunction with the LIM-homeobox gene Xlim1. Furthermore, we were able to demonstrate an interaction between Ssdp and Chip (the fly homolog of Ldb1) in Drosophila wing development. These findings indicate functional conservation of Ssdp as a cofactor of Ldb1 in transcriptional regulation during invertebrate and vertebrate development. The Section has identified a number of novel genes involved in the development of the mouse embryo. The first two of these, Thg-1pit and MPP 2, were detected in a screen for genes that are differentially expressed in the developing pituitary of wild-type and Lhx3 null mutant embryos. The genes are active at early stages of pituitary development. A third gene, Mbx, encodes a homeodomain transcription factor that is initially restricted to the midbrain region of the mouse embryo but later extends to the developing forebrain. Finally, we cloned Frcp1 and Frcp2, two genes that are also primarily expressed in the brain. These genes contain a FNIII motif characteristic for a variety of receptor and cell adhesion proteins.